Core A: Administrative Core

CORE A: PROJECT ABSTRACT
The responsibilities of the Administrative Core include monitoring and planning of scientific activities, providing scientific direction for the SPORE, ensuring an interdisciplinary translational research emphasis and integration within each participating institution and NCI Translational Research Programs. The Administrative Core is managed by Co-Directors Dr. Christopher Flowers and Dr. Jean Koff, who will preside over the scientific quality of the Lymphoma Outcomes SPORE and ensure communication, cooperation, and integration between the different components of the SPORE Program. The primary goal of this Core is to assure the successful oversight and coordination of all projects, cores, career enhancement and developmental research program through expert guidance in fiscal management, centralized communication, and general administration for all activities. The Administrative Core will provide leadership and coordinate the activities of the Executive Committee (which consists of Project Co-Leaders and Core Co- Directors), the External Advisory Board members and the Community Advisory Board members. Specific responsibilities of the Administrative Core include: 1) to oversee all projects and cores, 2) to oversee the Career Enhancement and Developmental Research Programs, 3) to convene all meetings of the SPORE Executive Committee, and Community/External Advisory Boards, 4) to schedule and organize all necessary meetings, including monthly scientific meetings, lectures, symposia, and attendance at any NCI-sponsored meetings/workshops, 5) to coordinate data quality control and quality assurance in conjunction with the Internal Review and Monitoring Committees of MD Anderson, 6) to monitor and oversee all fiscal and budgetary issues, 7) to initiate collaborative research with other SPOREs through electronic communications or joint meetings, 8) to communicate with the NCI Program Officer and other NCI staff to prepare all required reports and publications, 9) to notify the NCI Program Officer promptly of important developments that affect the management of the SPORE either positively or negatively, and 10) to assure compliance with all institutional, federal, and NCI/NIH regulations and requirements. Additional objectives of the Administrative Core will be to organize the annual scientific conferences and community events directed to populations affected by lymphoma.

Public health relevance
The responsibilities of the Administrative Core include monitoring and planning of scientific activities, providing scientific direction for the SPORE, ensuring an interdisciplinary translational research emphasis and integration within each participating institution and NCI Translational Research Programs.